Molecular and Cellular Basis of Craniosynostosis

During fetal development and early childhood, growth of the bony skull accommodates a rapid expansion of the
underlying brain. This is accomplished first by progenitors that grow the individual skull bones, and then by stem
cells residing in the flexible bony joints called sutures. In a common birth defect called craniosynostosis (1 in
2000 live births), loss of the cranial sutures results in bony fusions that impede brain growth, thus leading to
cognitive impairment if left untreated. Surgical correction involves invasive and risky surgeries on infants to break
apart the fused bones. Unfortunately, the skull bones often re-fuse, necessitating repeated surgeries. There is
thus a critical need to better understand the causes of craniosynostosis, such that we can develop therapies that
minimize repeated surgical interventions. In the previous funding cycle, we generated and characterized the first
zebrafish model of Saethre-Chotzen Syndrome, which preferentially affects the coronal suture. In so doing, we
pinpointed early changes in the growth rates of the embryonic skull bones as a major cause of suture fusions. In
this renewal we address three outstanding questions in the field of craniosynostosis. In Aim 1, we investigate
the embryonic origins of the suture stem cells that grow and maintain the skull. While suture stem cells have
been studied at postnatal stages, whether they arise from progenitors at the tips of growing bones, or alternatively
from migrating cells, remains debated. By generating the first single-cell transcriptomes of the developing mouse
and zebrafish coronal sutures, we have uncovered conserved embryonic cell types and molecular markers for
suture progenitors. Using new lineage tracing tools in mouse and fish, we will test that bone front progenitors
expressing ETS-family transcription factors are the origin of suture-resident stem cells. In Aim 2, we investigate
how the Saethre-Chotzen genes Twist1 and Tcf12 regulate the transition from bone front progenitors to suture
stem cells. Preliminary data reveal that Twist1 and Tcf12 upregulate the Bmp antagonists Grem1 and Noggin
during suture formation, suggesting that tighter regulation of Bmp signaling is essential to slow bone growth and
prevent fusions. Using mouse conditional genetics and new zebrafish mutants, we will test that direct regulation
of Grem1 and Noggin expression by Twist1 and Tcf12 is necessary and sufficient for regulated bone growth and
normal suture formation. In Aim 3, we address a central mystery of the craniosynostosis field – why do particular
mutations tend to affect only particular sutures? By generating and contrasting new zebrafish models for 11
coronal and 7 midline craniosynostosis genes, we will test whether coronal suture formation is particularly
sensitive to mutations that perturb the rate of bone growth. To do so, we will make use of new zebrafish
transgenic reporters that allow quantitative in vivo measurements of osteoblast addition and suture formation. A
strength of the proposal is the unique team of experts in zebrafish, mouse, and human craniofacial genetics. By
using model organisms to understand the developmental bases for diverse types of craniosynostosis, we strive
toward developing more targeted treatments for craniosynostosis patients with particular genetic mutations.

Public health relevance
This is a proposal to study the formation of the sutures that separate and grow the skull bones. Our over-arching goal is to broadly understand how distinct genetic mutations cause craniosynostosis by disrupting distinct embryonic processes, with a particular focus on coronal suture fusions in Saethre-Chotzen Syndrome. A better understanding of how particular mutations disrupt suture formation should aid in developing patient-specific approaches toward preventing post-operative fusions of sutures.